Pathways for innovation in Blood Transfusión Systems in Kenya (PITS Kenya)

PROJECT SUMMARY/ABSTRACT
There is a critical shortage of blood that affects many countries in Sub-Saharan Africa. Blood
collection rates in these regions are ten-fold lower than rates in high-income countries.
According to the Kenya National Blood Transfusion Service (KNBTS), the country's healthcare
system requires nearly 500,000 units of blood per year. Last year, collections reached just 30%
of this mark. Unfortunately, the blood transfusion processes span a continuum from blood
donation to safe delivery that is complex, expensive, and prone to failure. The consequences
are devastating; postpartum hemorrhage, malarial anemia, sickle cell disease, and all other
forms of acute hemorrhage claim millions of lives each year. Thus, optimizing blood transfusion
services in LMICs represents both a major health challenge and a social imperative. The
overarching goal of this project is to identify, develop, and test effective strategies to enhance
the availability and delivery of safe blood for transfusion in Kenya. A research consortium led by
Strathmore University and the Center for Public Health and Development (CPHD) in Nairobi has
partnered with the University of Pittsburgh with the objective of defining and characterizing the
blood transfusion system in Kenya in order to provide evidence for the effective implementation
of a diverse set of interventions aimed at enhancing and streamlining the safe delivery of blood
in both urban and rural Kenya. Our research team has designed a multidimensional three-by-
three-by-three approach that consists of three clinical pathways determining the urgency of
blood transfusions; three distinct socioeconomic contexts within Kenya that best represent both
urban and rural settings; and three basic components of effective blood transfusion systems
(availability, processing, and safe delivery). Our specific aims are: 1. Evaluate ground-level
deficits in the continuum of banked blood transfusion — specifically availability, processing, and
delivery — across three distinct socioeconomic contexts in Kenya (Nakuru, Siaya/Kisumu, and
Turkana counties), and within three specific clinical contexts (emergent, urgent, planned); 2.
Evaluate ground-level and consensus solutions to optimize the continuum of banked blood
transfusion; and 3. Identify disruptive technologies for the implementation of safe and reliable
blood transfusion strategies, including innovative supply-chain solutions and crowd-sourcing
through social media and mobile technologies. This work will elucidate barriers to safe blood
access and quantify the impacts of unavailable blood in each clinical situation. During the UH3
phase of the project, we aim to implement innovative, contextually appropriate, stakeholder-
backed interventions to address deficits across the blood continuum, ultimately optimizing blood
donation, collection, testing, and timely availability so that blood is given to the right patient at
the right time and location, ensuring the highest quality of blood transfusion services in low
resource areas.

Public health relevance
PROJECT NARRATIVE Optimizing blood transfusion services in LMICs represents both a major health challenge and a social imperative; postpartum hemorrhage, malarial anemia, sickle cell disease, and all other forms of acute hemorrhage claim millions of lives each year across the world. We have assembled an international, multidisciplinary team to explore gaps and identify solutions across the blood continuum in a diverse set of sociopolitical contexts within Kenya's current health setting. We seek to implement supply chain solutions and innovative-disruptive techniques aimed at ensuring sustainability and generalizable to similar contexts within the Sub-Saharan subcontinent.